Randomized clinical trial to test the efficacy of a smartphone app for smoking cessation for nondaily smokers

Project Summary
Nondaily smoking is an increasingly prevalent pattern of smoking with substantial health detriments. Currently,
25% of all U.S. adult smokers are nondaily smokers, and this prevalence has increased by 27% in the last
decade. Formerly believed to be a transient pattern of smoking, research has established that nondaily
smoking is often a persistent pattern. Nondaily smoking is more prevalent among Black and Latinx persons in
the United States and is increasingly prevalent among people with serious mental health issues. Despite
substantial harms associated with nondaily smoking, the U.S. Clinical Practice Guidelines for smoking
cessation offer no guidance on how to support nondaily smokers in smoking cessation due to a lack of
evidence for efficacious approaches. A continued failure to address nondaily smoking widens existing health
disparities at an increasingly accelerated rate. Empirically supported interventions are critically needed. Only
two trials to date have targeted nondaily smoking cessation. Both focused on pharmacological options, and
both failed to show efficacy in achieving smoking abstinence. Our team has developed a behavioral treatment
for nondaily smokers: the Smiling Instead of Smoking (SiS) smartphone app. This app utilizes positive
psychology exercises to enhance engagement of nondaily smokers and to maintain positive affect while they
undergo a quit attempt. This approach is based on nondaily smokers' preference to focus on positive self-
identity and wellness, and evidence that shows that greater positive affect is associated with increased self-
efficacy to quit smoking, decreased desire to smoke and greater readiness to process self-relevant health
information, all of which are constructs highlighted in dominant health behavior theories as causal agents in
successful behavioral change. In collaboration with nondaily smokers, we have rigorously and iteratively
developed and tested this app in a series of small-scale studies. This work has demonstrated the app's ability
to engage nondaily smokers, and has shown proof-of-concept efficacy in a small, randomized trial, where
participants using the SiS app had significantly higher self-efficacy, lower craving and higher positive affect at
the end of treatment, compared to controls. We now propose to test the efficacy of this app to improve 6-month
abstinence in a large-scale, single-blind, remote, parallel, randomized clinical trial comparing the SiS app to the
NCI's app “QuitGuide”. All participants will be asked to set a quit date and to use the provided app for 7 weeks,
1 week prior to and 6 weeks after their quit date. Online surveys will be conducted at enrollment and 2, 6, 12,
24 and 52 weeks after the initially chosen quit date. The primary outcome measure will be 30-day point
prevalence abstinence 6 months post quit. If found to be efficacious, this study would provide the first evidence
of an efficacious treatment for nondaily smokers, for whom currently no treatment guidelines exist.

Public health relevance
Project Narrative The goal of this project is to test the effectiveness of a novel behavioral treatment for nondaily smokers; namely a smartphone app that engages app users in positive psychology exercises to bolster their positive affect as they undergo the process of quitting smoking. This app has been rigorously and iteratively developed with and for nondaily smokers. If found effective, it would be the first treatment for nondaily smokers found to be effective.